Developing Tools to Facilitate Dynamics-Based Drug Discovery of Receptors of Drugs of Abuse

Project Summary/Abstract
Many drugs of abuse target G protein coupled receptors (GPCRs), including the opioids which have fueled the
ongoing opioid abuse epidemic. Many of these compounds have substantial room for improving their therapeutic
window by precisely tuning their signaling profiles. However, rational design of such compounds is difficult due
to a lack of understanding of how these compounds alter the structure and dynamics of receptors to relay their
pharmacological profile intracellularly to their signaling partners. Here we propose to generate chemical biology
tools to facilitate the determination of molecular movies of GPCRs interacting with their signaling partners with
time-resolved cryogenic electron microscopy. This will be complemented by the development of a new
computational method to drive simulations from time-resolved cryogenic electron microscopy data in order to
fully sample all of the transition and intermediate states involved in GPCR signaling. These methods will be
applied to several ligands of various efficacies for a key receptor for drugs of abuse, and the insights used in
ultra-high throughput virtual screening campaigns to identify novel allosteric modulations to stabilize specific
intermediate states. Finally, allosteric compounds will be tested in rodent models of addiction to explore how
modulation of these specific intermediate states attenuates the addiction liability of canonical drugs of abuse.

Public health relevance
Project Narrative Some drugs of abuse, for example opioids, bind to the same receptor but with significantly differences in the response and addictive potential in the body. In this grant we propose to develop tools to enable us to use computer simulations and electron microscope imaging to make ‘movies’ of different drugs of abuse signaling at their receptors to better understand this behavior. To demonstrate the value of these movies we will use them to generate new compounds for modulating drug use disorders, and test their effects in rodent models.